Response to Exercise and Nitric Oxide in PAD: the RESIST PAD Trial

Walking exercise is the only highly effective medical therapy that improves walking impairment in people with
lower extremity peripheral artery disease (PAD). However, approximately 45% of people with PAD do not
meaningfully improve in response to exercise. Biologic pathways that mediate the beneficial effects of
exercise and biologic explanations for non-response to exercise in PAD are unknown. Based on our
preliminary data, we hypothesize that exercise-induced shear stress stimulates nitric oxide synthase to
increase nitric oxide (NO) bioavailability during exercise, thereby improving leg perfusion, skeletal muscle
mitochondrial activity, and walking ability in PAD. We further
people without cardiovascular disease between the beginning
Maximal exercise test start Maximal exercise test end and end of a maximal exercise test, but declined by 44.2%
Figure. Δ nitrite: Change in plasma nitrite during a between the beginning and end of a maximal exercise test in
maximal exercise test
29 untrained people with PAD (Figure). In this trial, change in
plasma nitrite between beginning and end of a maximal exercise test is defined as “Δ nitrite”. In preliminary
study, we reported that a 12 week exercise intervention significantly increased Δ nitrite at 12 week follow-up in
people with PAD (Figure). Greater Δ nitrite increases were associated with greater walking improvement (r
squared =0.59, <0.01). We now propose a mechanistic randomized trial of supervised exercise in 200 people
Plasma Nitrite
hypothesize that exercise increases plasma NO during
exercise in “responders”, but that exercise does not
meaningfully increase NO during exercise in “non-
Improvement responders”. NO has a short half-life and is oxidized to nitrite,
with exercise a more stable measure of NO abundance. We previously
demonstrated that plasma nitrite increased by 39.3% in 41
with PAD to test these hypotheses: 1) that a 12 week exercise intervention significantly increases Δ nitrite at
12-week f/up, compared to a no-exercise control; 2) that exercise “responders” have greater Δ nitrite increases
than “non-responders”; 3) among non-responders to 12 weeks of supervised exercise, that supplementing
exercise with nitrate-rich beetroot juice for an additional 12 weeks increases Δ nitrite and improves 6-min. walk
at 24-week f/up, compared to placebo; 4) that greater increases in Δ nitrite are associated with greater
improvements in calf muscle perfusion and mitochondrial activity, brachial artery FMD, and 6-minute walk. If
our hypotheses are correct, this trial will, for the first time, establish Δ nitrite as a critical mediator of
the benefits of exercise in PAD. Results will also delineate a key biologic pathway of exercise non-
response, thereby identifying an important therapeutic target for future interventions in PAD.

Public health relevance
PROJECT NARRATIVE Although supervised exercise is first line therapy for people disabled by lower extremity peripheral artery disease (PAD), 45% of people with PAD do not meaningfully improve after exercise. This clinical trial of supervised exercise in PAD will test the hypothesis that changes in plasma nitrite levels during exercise activity mediate response to exercise and that people who do not respond to exercise fail to increase plasma nitrite levels during walking exercise activity. Results will be used to identify therapeutic targets for future interventions, to improve walking performance in people disabled by PAD.